Regional Oncology Research Center (Heterogeneity)

PROJECT SUMMARY/ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
24-032. Black women have the highest breast cancer mortality rate and shortest overall survival among all
racial/ethnic groups of women in the United States. Adverse social determinants of health (SDoH) (e.g.,
structural racism) are documented sources of racial disparities in breast cancer. However, research studies
examining the mechanistic pathways of these associations and those examining within-group differences among
Black women are lacking. This study seeks to overcome these limitations of current research by examining the
extent to which SDoH measures are associated with inflammatory biomarkers among Black women. We will
recruit a socio-demographically heterogeneous sample of Black breast cancer survivors from Maryland.
Participants will provide survey data, blood samples, and qualitative data. Integrating these data, we will assess
associations and generate new hypotheses about the influence of adverse SDoH on breast cancer among Black
women. In Aim 1 of the study, we will examine associations between SDoH, patient-reported outcomes, and
inflammation-related protein biomarkers in a sample of 100 socio-demographically diverse Black BC survivors.
We will employ statistical and laboratory analyses to examine associations of SDoH measures and health-related
quality of life with inflammatory biomarkers overall and explore stratifications by measures of individual
socioeconomic position. In Aim 2 of the study, we will conduct eight focus groups with a subset of participants
from Aim 1. Focus groups will be homogeneous by age group and area of residence to more comprehensively
understand within-group lived experiences related to SDoH and breast cancer. We will integrate qualitative
analyses with findings from Aim 1 using a mixed methods analytic approach. The study is strongly aligned with
NOT-CA-24-032 and with the priorities of the parent grant (P30CA006973). Findings will provide insight into how
social factors can impact inflammation and cancer outcomes in varied socio-demographic subgroups of Black
women.

Public health relevance
PROJECT NARRATIVE Adverse social conditions contribute to poor breast cancer outcomes among Black women. This study will collect and analyze data from surveys, biospecimens, and focus groups among Black women with breast cancer to study associations between social determinants of health, biomarkers of inflammation, and health-related quality of life. Study findings will increase understanding of how social factors may contribute to racial disparities in breast cancer and help identify strategies to improve health outcomes among Black women with breast cancer.